DEVELOPMENT OF FAST, ANALOG TIME DOMAIN LIFETIME IMAGING SYSTEM

Determination of two-photon excitation cross-sections usually requires exact values of dye concentrations. These values can be subject to errors and uncertainties. Since FCS gives direct access to the fluorescence emission rates per single molecule, cross-sections can be determined totally independent from concentrations. Knowing one-photon cross-sections, the comparison of output signals of the same dye solutions for both excitation schemes yields information about the two-photon variant. This has been done so far for Rhodamine derivatives (TMR, Rhodamine Green) and for green fluorescent protein